Cortical Integration in Humans: An Intracranial Investigation of Neural Synchrony

PROJECT SUMMARY / ABSTRACT
It is unknown how the 16 billion neurons in the human cortex coordinate to integrate diverse streams of
information into coherent perception, cognition, and action. Understanding the mechanisms of cortical
integration is crucial for unraveling how the brain orchestrates thought and behavior—a problem that is at the
heart of all neurosciences. However, the mechanisms of cortical integration remain unclear for two primary
reasons (1) recording devices typically used in humans, such as EEG and fMRI, are limited in spatial and
temporal resolution, which constrains our ability to measure neural activity; and (2) although much research
has focused on the localization of specific cognitive functions to different cortical areas, less attention has been
paid to understanding how functional activity in those areas is integrated.
This proposal aims to leverage rare intracranial recordings in humans during cognitive tasks to investigate
the neural mechanisms underlying cortical integration across multiple domains. These invasive recordings of
local field potentials (LFP) and single units offer unparalleled spatial and temporal resolution. Recent work in
human intracranial electrophysiology has identified cortical ripples as a promising indicator of cortical
integration. These brief, high-frequency oscillations co-occur and synchronize across distant regions of the
cortex during cognitive tasks. Specifically, synchronized ripples form a highly interconnected frontoparietal
network prior to correct semantic judgments. Furthermore, coordination of single-neuron firing in different
cortical locations is enhanced when both locations are rippling. Together, these results suggest that ripples are
a strong candidate for involvement in cortical integration. This study will expand upon these observations by
investigating ripple co-occurrence in new contexts to better understand their function in the brain.
To date, ripple synchrony has only been rigorously studied in semantic judgment tasks to visual words. This
work aims to explore whether ripple synchronization extends to other sensory modalities (auditory words) and
cognitive domains (facial processing). Ripple-modulation of single units has only been studied during
spontaneous behavior at short-range. This study will expand upon those results to determine whether ripple-
modulation of units extends to other tasks and longer ranges. Finally, ripple networks during tasks have only
been studied in the left hemisphere. This study will investigate if ripple synchronization occurs in and between
both hemispheres. This study will use a combination of archival, open source, and novel data with a variety of
recording types to accomplish these goals. The results of this project will provide critical insights into the
function, distribution, and dynamics of the brain and will shed light on the mechanisms of cortical integration
in humans.

Public health relevance
PROJECT NARRATIVE Disruptions in cortical integration are associated with a variety of neurological and psychiatric disorders that are poorly understood and urgently need better treatment options, such as schizophrenia, dementia, ADHD, and many more. Furthermore, due to ethical reasons, much of the research that is performed to study the basic neurophysiology underlying these diseases is performed in rodents. Developing a better understanding of the human neurophysiology underlying the processes which are disrupted is essential to developing efficacious treatments for them and the research highlighted in this proposal has the potential to inform such models and treatments.